Close-Loop Deep Brain Optoacoustic Stimulation at Sub-millimeter Precision

Neuromodulation has been an invaluable approach for basic studies of neural circuits and for effective clinical
treatment of neurological diseases. Electrical stimulation is widely used and forms the basis of current
implantable devices. For example, the applications of electrical stimulation based deep brain stimulation (DBS)
has been applied to epilepsy, Parkinson’s disease and depression, and is rapidly expanding, with more than 350
trials and 62% them for movement disorders1. Yet, the limited spatial precision due to current spread, fMRI
incompatibility due to metal and electronic components, and interference with the electrical recording required
for the closed loop control limit the further improvement of the existing electrical implants, such as DBS. These
limitations highlight an unmet need for new non-genetic, highly precise, fMRI compatible, and translatable neural
stimulation technologies. Here we propose a non-genetic deep brain optoacoustic neural stimulation (DBOAS)
technology through a multiple functional fiber based optoacoustic emitter (mFOE). We integrate conducting
electrodes and optoacoustic emitters converted from polymer optical fibers into a miniaturized multifunctional
fiber. Such mFOE enables a sub-100-micron stimulation at the each site for volumetric stimulation by selective
light guiding. It provides closed loop control without electrical interference. We will design the volumetric mFOE,
validate our hypothesis through a system design for DBOAS, and evaluate treatment effect of the closed-loop
DBOAS in a mouse epilepsy model. A multi-disciplinary team with complementary expertise is assembled to
perform the proposed activities. Prof. Chen Yang (PI) is an expert in nanomaterials and nanomaterial-based
devices for neuromodulation. Prof. Xiaoting Jia (co-I) is an expert in polymer fiber devices for optogenetic brain
modulation and electrical recording. Prof. Ji-Xin Cheng (collaborator) is an expert in optics and photoacoustic
devices. Dr. Jeffery Schweitzer (collaborator, MGH) is a neurosurgeon and an expert in implantable treatments
for neurological disorders, such as epilepsy. We focus on closed loop DBOAS in this project, and its potential
applications in other clinical conditions and fundamental studies are broad, including treating neurological
diseases in brain, coded retinal stimulation and brain-machine interface.

Public health relevance
Project Narrative Neuromodulation has been an invaluable approach for basic studies of neural circuits and for effective clinical treatment of neurological diseases. The goal of the proposed R21 project is to develop a non-genetic high precision volumetric optoacoustic neural stimulation technology for deep brain stimulation with closed loop control. The potential applications in clinical conditions and fundamental studies are broad, including treating neurological diseases in brain, coded retinal stimulation and brain-machine interface.